Tumor Subtypes and Therapy Response in Pancreatic Cancer

ABSTRACT FOLFIRINOX (FFX) and gemcitabine plus nab-paclitaxel (GnP) have emerged as the first-line treatments for patients with pancreatic cancer (PDAC). These two regimens have not been compared in the first-line setting, and treatment selection is guided by physician's “best-guess”. Matching the most effective systemic therapy with the potential vulnerabilities of the tumor has been an unrealized hope for patients and a solid barrier to personalized medicine for PDAC. We have identified molecular subtypes of PDAC that are robust and replicable. We and others have found that basal subtype patients rarely respond to FFX, but show responses to GnP. Thus, identifying patients at initial diagnosis to optimize treatment is critical. Proteomic analysis of tumor samples shows differential kinase expression in basal tumors including previously known targets such as EGFR. Based on our findings of subtype association with treatment response, we have developed a robust and replicable single sample classifier PurIST assay that is now CLIA approved and ready. For this proposal, we will use CLIA PurIST for treatment selection of either FFX or GnP (PANCREAS trial, PI Tsai). To determine if repurposing anti- EGFR therapies specifically for basal tumor patients may be promising, we will analyze two completed clinical trials. To identify additional options for patients, we will evaluate two ongoing clinical trials that include cisplatin to GnP as well as paricalcitol and nivolumab. To develop alternative approaches and to overcome FOLFIRINOX resistance, we will identify new targets for basal tumors using a tailored CRISPR screen. Finally, we will use our deconvolution and single-cell methods to determine if the tumor and tumor microenvironment may be predictive of response in the therapies studied. Leveraging the strength of molecular subtyping expertise at the University of North Carolina at Chapel Hill and the tremendous neoadjuvant therapy infrastructure Medical College of Wisconsin's Pancreatic Cancer Program, we will conduct, to our knowledge, the first precision oncology trial in neoadjuvant PDAC patients. Results from this trial may revolutionize precision oncology approaches such as PurIST for PDAC.

Public health relevance
PROJECT NARRATIVE Leveraging the strengths of molecular subtyping expertise and neoadjuvant therapy infrastructure, we propose to determine if tumor-intrinsic subtypes may be used to select a wide range of therapies. Based on analysis of prospective trials where the basal subtype is resistant to FOLFIRINOX, will use CLIA-approved PurIST direct the initial chemotherapy selection. To our knowledge this will be the first trial to use molecular subtyping to direct treatment in the neoadjuvant setting. The overall goals of this proposal are to determine optimal therapies for patients with basal tumors, and establish a precision medicine approach using subtypes in pancreatic cancer.